Integrated Genomic-Transcriptomic Characterization to Identify Molecular Mechanisms of Disparities in PDAC Outcomes

Abstract
Despite advances in diagnostic and therapeutic modalities, the 5-year survival of patients with pancreatic
adenocarcinoma (PDAC) remains woefully low. Unfortunately, African Americans (AA) bear a disproportionate
brunt of this disease and both the incidence and mortality of PDAC are higher amongst them. Better
understanding of the causes of these disparities will help develop novel strategies to address them.
Pancreatic cancer is a mutation-driven cancer. Alterations in tumor driver genes like KRAS, TP53, SMAD4 and
CDKN2A alter multiple transcriptional pathways in the native pancreatic cells and their microenvironment,
resulting in tumor growth, progression and metastases. Presence or absence of many of these mutations can
modulate the aggressiveness of cancer and the clinical course of patients with PDAC. Studies in other
cancers including colon, breast and prostate cancer, have demonstrated that differing genomic and
transcriptional landscape amongst Caucasians (CA) and AA can explain some of the racial health
disparities with respect the incidence and the outcomes of these cancers. However, such data in the
context of PDAC is lacking. Given that a) genomic-transcriptomic signatures shape PDAC progression and
outcomes; b) AAs and CAs have difference in pancreatic cancer incidence and outcomes irrespective of tumor
stage; and c) race is associated with differential mutational and transcriptional signatures in multiple other
cancers, we have put forth the following hypothesis to explain the racial health disparities in context of PDAC:
Hypothesis: Differences in the genomic and transcriptomic signatures contributes to the disparities in
pancreatic cancer incidence and outcomes between African Americans and Caucasians. Our hypothesis will
be tested through the two specific aims: Aim 1 will be focused on interrogating the mutational landscape of
PDAC using deep whole exome sequencing (WES) on resected tumor specimens of histologically proven
PDAC cases from AA PDAC patients. In addition to testing specific hypotheses about KRAS, we will screen for
potential pathogenic variants (PPVs) which could be contributing significantly to the outcome disparities
between CA and AA PDAC patients. In Aim 2 Bulk RNA sequencing (RNA-seq) will be performed on the
cohort of 100 PDAC specimens from AA patients (from aim 1) to identify clinically relevant transcriptional
pathways in AA PDAC tumors in two ways. First, the AA and CA cases will be compared according to our
published PurIST algorithm to understand the incidence of classical/basal tumor subtypes, which predict
response to frontline therapy. Additionally, we will perform De-novo transcriptomic subtyping and pathway
analysis to understand whether AA PDAC tumors harbor distinct transcriptional signatures compared to those
identified previously in CA cases. Successful execution of the current studies will provide, for the first time,
detailed analysis of genetic and transcriptional landscape of PDAC in AAs when compared to CA. These data
will help us better understand the potential reasons of racial health disparities and will help us develop novel
strategies to address these and thus achieve racial health equality.

Public health relevance
African Americans bear a disproportionate brunt of pancreatic cancer (PDAC) and both the incidence and mortality of PDAC are higher amongst them. Better understanding of the causes of these disparities will help develop novel strategies to address them and thus achieve racial health equality. In the current grant proposal, we will evaluate the differences in the mutational and transcriptional landscape between the PDAC in African American and Caucasians and will evaluate the contribution these differences to the disparities in pancreatic cancer incidence and outcomes between African Americans and Caucasians.